LAMB request for Surgical Suite Upgrade

Project Abstract This project will allow an upgrade to the surgical suite in the vivarium with a particular emphasis on the infectious containment capabilities. The upgraded infectious unit equipment will facilitate the performance of larger-scale, more complex experiments by allowing more than one user/surgeon to use the biocontainment unit at the same time, as well as decrease the risk of cross-contamination between labs using different infectious agents and decrease the risk of infection to the users. In addition, having a dedicated rodent anesthetic unit will shorten anesthetic duration, and heated surgical table will prevent intra-operative hypothermia, thereby greatly enhancing the quality of the surgeries and procedures and well-being of the animals being administered infectious agents. The equipment being proposed entails the purchase and installation of the following into the VMU infectious suite: - Two (2) Class II Type B2 (i.e., hard-ducted) 4 foot biosafety cabinets; - Rodent anesthetic system solely dedicated to the infectious suite; - Built-in heated surgical table; - Built-in autoclave.

Public health relevance
Project Narrative Upgrading the outdated vivarium surgical suite and ensuring it is outfitted with the most current infectious containment equipment will support the growing portfolio of infectious disease research using animal model at this facility. The suite is located in the vivarium and the VA Ann Arbor has a rich history of animal research and contributions stemming from its animal research portfolio.